Electrophysiological Events Underlying Human Gastric Motility.

PROJECT SUMMARY
The stomach is a remarkable organ that can accept and store considerable volumes of food, reduce the size of
food particles to a suitable size, and efficiently empty nutrients into the duodenum. Unfortunately, functional
disorders of gastric motility plague many people and effective therapies are lacking because basic mechanisms
of human gastric motility are poorly understood. Much of what is known about gastric electrophysiology is
derived from studies of laboratory animals, but such extrapolation may or may not accurately describe
mechanisms of human gastric motor activity. The mixed genetic background of humans also makes
generalization of concepts more complicated. In addition, little is known about sex differences, ethnicity or the
effects of aging on gastric pacemaker mechanisms. Yet gastric motor disorders, such as gastroparesis or
functional dyspepsia, are more prevalent in women and enhanced with age. In this project we will exploit a rare
opportunity to systematically investigate the morphology and molecular phenotype and electrophysiology of
human gastric muscles. It is possible that new weight-loss drugs (e.g. GLP-1R agonists; SGLT-2 inhibitors) will
reduce the need for bariatric surgery. Thus, opportunities to study human gastric muscles may decrease in the
future. Three specific aims will be pursued in this project: (i) Characterize the morphology and molecular
phenotype of interstitial cells of the SIP syncytium in human gastric muscles. ii) Investigate the mechanisms
responsible for pacemaker activity and slow wave propagation in the human stomach. iii) Investigate the
functional role of PDGFRa+ cells and integrated regulation of gastric electrical and mechanical activity resulting
from inputs of ICC and PDGFRa+ cells. Our experiments will utilize intracellular microelectrode recordings from
human gastric muscles in vitro. This technique provides recordings of authentic transmembrane
electrophysiology that will allow evaluation of the mechanisms responsible for electrical slow waves. Single
nuclei gene expression studies (snRNA-seq) will determine additional components of the human gastric
pacemakersome, and Ca2+ imaging will characterize Ca2+ handling mechanisms in ICC and SMCs. Additional
studies will investigate the morphological and functional components of active propagation in gastric muscles.
This project will develop a mechanistic description of electrical rhythmicity in human gastric muscles, clarify
similarities and differences between gastric pacemaker activity in humans and laboratory animals, and provide
novel baseline information that will be useful for physicians and the development of therapeutics for gastric
motility disorders.

Public health relevance
PROJECT NARRATIVE Functional disorders of the stomach plague many patients in the United States and present significant health care costs. Relief from these problems depends upon better understanding of the mechanisms underlying gastric motor activity. To date, little is known about mechanisms of electrical pacemaker activity and propagation of electrical activity in the human stomach, and many clinical diagnoses and decisions rely heavily on information obtained from studies of laboratory animals. This proposal examines the mechanisms underlying human gastric motility and will provide the first systematic NIH investigation of living human gastric muscles at a cellular and mechanistic level. We believe the results collected will help physicians understanding of how the human stomach generates and propagates the peristaltic contractions necessary for efficient gastric emptying and provide new ideas to pharmaceutical companies attempting to design and implement effective treatments for functional gastric disorders.